Roles for Ets1 in thymic selection and CD8αα IEL development

PROJECT SUMMARY
Thymic selection is crucial for generating functional and self-tolerant T cells, yet the mechanisms
underlying the development of unconventional T cell lineages, such as CD8αα intraepithelial lymphocytes
(IELs), remain poorly understood. CD8αα IELs possess innate-like features and play essential roles in
maintaining intestinal integrity. Dysregulation of CD8αα IELs can contribute to intestinal pathologies like celiac
disease. This study focuses on investigating the role of the transcription factor Ets1 in thymic selection and its
impact on IEL development and function. Ets1 is a signal-regulated transcription factor that is implicated in the
pathogenesis of multiple autoimmune disorders. Despite its known roles in early T cell development and
peripheral T cell function, Ets1’s specific role in thymic selection remains poorly understood. Furthermore, Ets1
is implicated in regulating responses to IL-15 and TGF-β, crucial for CD8αα IEL maturation and function,
highlighting its significance in intestinal homeostasis. Preliminary data using Ets1-deficient mice indicate that
Ets1 restricts the development of IEL precursors (IELps) in the thymus and prevents premature egress of
immature thymocytes. Moreover, Ets1 may promote clonal deletion of autoreactive T cells. This study aims to
elucidate the molecular mechanisms underlying these observations. Aim 1 aims to determine how Ets1
regulates thymic selection by investigating its impact on positive selection and clonal deletion. TCR-transgenic
models, flow cytometry, and CUT&RUN will be used to determine how Ets1 regulates thymic selection. Aim 2
focuses on assessing the functional consequences of Ets1 deficiency in CD8αα IELs. By examining IELp
maturation and peripheral function, this aim aims to elucidate how Ets1 influences the development and
function of these cells. Overall, this study aims to provide novel insights into the regulatory mechanisms
governing thymic selection and the role of Ets1 in shaping T cell development and peripheral immune
homeostasis, with potential implications for understanding autoimmune diseases.

Public health relevance
PROJECT NARRATIVE This research delves into the critical processes of thymic selection and the function of CD8αα intraepithelial lymphocytes (IELs), shedding light on fundamental aspects of immune system regulation. This proposal focuses on the regulation of these processes by Ets1, a transcription factor identified as a risk allele for several autoimmune disorders. Understanding the role of Ets1 in thymic selection and IEL function will provide insights into autoimmune diseases and intestinal pathologies, potentially paving the way for the development of novel therapeutic strategies to improve public health outcomes.